De novo mutations in replication-independent histone genes and an unexplored class of rare pediatric mendelian syndromes

PROJECT SUMMARY
Heterozygous germline missense mutations in replication-independent (RI) histones are emerging as the
cause of histonopathies, a devastating class of pediatric neurodevelopmental disorders (NDDs). However, the
neurobiological function of histones in human pathology and, more broadly, in development is understudied. In
part, this is due to the high degree of homology shared by the ~100 histone encoding-genes, which has
historically rendered them refractory to genetic sequencing. This proposed work builds on our innovative histone
variation intolerance prediction project that we pursued to overcome traditional histone-specific limitations. In my
2022 publication of this work, we more than doubled the list of RI-histonopathy disease genes from 3 to 8. We
have since built unpublished cohorts of patients for 4 of the 5 novel disease genes, including an unrelated cohort
who share a pathogenic de novo heterozygous germline missense mutation in MACROH2A1 (c.80G>A,
p.R27Q). Our patients’ phenotypes exhibit substantial overlap with those of patients harboring heterozygous
missense mutations in other RI histones, suggesting a shared pathogenic mechanism. We hypothesize that this
MACROH2A1 de novo heterozygous germline missense mutation causes an NDD through a gain-of-function
mechanism that results in destabilization of the nucleosome and transcriptional de-repression. In Aim 1, we will
interrogate fundamental features of MACROH2A1 in a human model of neurodevelopment, which enables us to
probe human-specific processes that cannot be modeled in other systems. Further, the phenotypic overlap
between our patients and those with other RI-histonopathies suggests that studying how the recurrent
MACROH2A1 mutation perturbs human neurodevelopment will provide key insights into other histonopathies.
Thus, in Aim 2, we will quantify the epigenetic dysregulation caused by our patients’ mutation. This work will be
performed in the extensively characterized KOLF2.1J-background hiPSC line. We are employing a multifaceted
approach involving analysis of publicly available transcriptomic data, RT-qPCR, quantitative mass spectrometry,
ChIP-seq, CUT&RUN, cytosine base editing, bulk RNA-seq, EdU incorporation assays, FACS analysis, nuclear
co-immunoprecipitation and ATAC-seq to complete these aims. Our results will advance the field of
developmental histone biology and have great translational impact, including establishing a foundation for
therapeutic development for the histonopathy patient population that currently only receives palliative measures.
The proposed work will be carried out in the world-class training environment cultivated between the University
of Pennsylvania and the Children’s Hospital of Philadelphia, within the Bhoj Lab, which has a history of making
profound advances in the histone biology field. Additionally, the guidance from an exceptional sponsorship team
of Drs. Bhoj and Hakonarson, in conjunction with collaborators who are pioneers in their fields, will enable the
successful completion of this fellowship proposal and the development of a competent, independent investigator
capable of producing rigorous and reproducible patient-driven work.

Public health relevance
PROJECT NARRATIVE Histone proteins are core genome organizers that are essential for regulating gene expression and chromatin structure, which are roles emphasized by an emerging class of rare pediatric neurodevelopmental disorders (NDDs) caused by germline missense mutations in replication-independent (RI) histone genes. Using an innovative approach that harnessed the power of large-scale databases, we predicted a subset of novel putative histone-encoding disease candidate genes most likely to cause disease when mutated, and subsequently identified a previously unpublished cohort of unrelated patients with a recurrent germline missense mutation in the RI histone MACROH2A1 (c.80G>A, p.R27Q) who presented to clinical attention with an NDD that shares a striking degree of phenotypic overlap with other mutant-RI histone-driven histonopathies. In this study, we will interrogate, for the first time, the fundamental features of MACROH2A1 in a human model of neurodevelopment and then quantify the resulting epigenetic dysregulation caused by this shared mutation, leading to evidence for a unifying model of heterozygous missense mutations in RI histones acting through a conserved pathogenic mechanism, which would provide the foundation for therapeutic development; and resulting in the advancement of the field of histone neurobiology, the benefits of which could extend to providing insights into common neurodegenerative pathologies, like Alzheimer’s Disease.